Functional consequences of ITPase deficiency and the impact of inosine misincorporation into the transcriptome

Project Abstract
Bi-allelic loss of function variants in the ITPA gene cause a fatal infantile multisystem developmental disorder
characterized by epileptic encephalopathy and dilated cardiomyopathy. ITPA encodes the inosine triphosphate
pyrophosphatase (ITPase) enzyme which hydrolyzes inosine triphosphate (ITP) and deoxyITP to prevent their
accumulation in cellular nucleotide pools and subsequent misincorporation during RNA and DNA synthesis. Although the
biochemical activity of ITPase is well understood, the molecular and cellular mechanisms underlying the pathology
resulting from ITPase deficiency are unknown. ITPase-deficient patient cells, mouse embryonic stem cells and tissues
contain high levels of misincorporated inosine within bulk RNA but deoxyinosine is undetectable within DNA, due to
active DNA repair processes. To investigate the functional consequences of ITPase deficiency and inosine
misincorporation into the transcriptome; Aim 1) Illumina RNA sequencing (RNA-seq) and Oxford Nanopore Long-Read
sequencing will be performed on CRISPR/Cas9-derived ITPA-null human induced pluripotent stem cells (iPSCs), pre- and
post-differentiation into neurons and cardiomyocytes to evaluate transcriptome deregulation (transcript abundance,
splicing and polyadenylation) and novel transcript isoforms. In parallel, inosine accumulation as a direct driver of
transcriptome dysregulation will be tested by culturing ITPA-null cells with inosine nucleoside in the culture media. The
resulting inosine misincorporation into total RNA will be measured using mass spectrometry prior to RNA-seq and long
read sequencing. Aim 2) The impact of ITPase deficiency and inosine misincorporation into RNA on translation will be
determined. Ribosome profiling (Ribo-Seq) of ITPA-null neurons and cardiomyocytes will be performed under basal and
inosine nucleoside treatment conditions to determine translation efficiency and to pinpoint mRNA targets of altered
translation. Inosine misincorporation into rRNA, tRNA and mRNA will be quantified using mass spectrometry and
potential activation of cellular stress markers will be investigated. The proposed work will identify transcriptome and
translation alterations resulting from ITPase deficiency. The findings of this research will aid in elucidating the unknown
pathogenic mechanism(s) underlying ITPase-deficiency and may reveal novel therapeutic targets for treating this rare
but fatal disorder. The impact of this work extends to other disorders of nucleotide pool maintenance and may shed
new light on our understanding of inosine in A-to-I RNA editing and gene expression during development and disease
from a unique perspective.

Public health relevance
Project Narrative Failure to maintain the integrity of cellular nucleotide pools containing the basic building blocks of DNA and RNA can cause severe developmental disorders. This proposal seeks to understand how ITPase enzyme deficiency and the resulting accumulation of the non-canonical nucleotide inosine triphosphate causes disease. The findings of this research have the potential to uncover novel factors important for healthy development and reveal innovative therapeutic strategies for addressing accumulation of non-canonical nucleotides in disease.